Development of novel PD1 agonist therapeutic strategies for multiple sclerosis

Project Summary/Abstract
Current multiple sclerosis (MS) therapeutic approaches are insufficient to maintain long-term immune
homeostasis and effectively recalibrate T helper cell imbalances in patients. There remains an unmet clinical
need for new strategies that restore and sustain immune tolerance in MS.
PD1 signaling plays a critical role in the maintenance of immune tolerance
. Altered PDL1/PD1 expression, and/or
blockade of PD1 signaling, results in the breakdown of immune tolerance and predisposes mice and humans to
the development of autoimmunity and tissue inflammation. For example, blockade of PD1 and its ligands can
exacerbate EAE, a mouse model of MS. In fact, we recently found that Smad7, a major molecule implicated in
autoimmunity, sustains intestinal and CNS inflammation in mice by limiting PD1 in T cells and PD1 ligands in
DCs, thereby dampening PD1-induced Tregs. Given the critical role of PD1 signaling in limiting tissue
inflammation and autoimmunity, PD1 could represent a therapeutic target of high clinical interest in MS.
However,
the impact of enhancing PD1 signaling for therapeutic benefit in EAE and MS has never been tested.
For this proposal, we began exploring PD1 agonists in human T cells. We found agonizing PD1 via
immunoglobulin fusion proteins PDL1-Fc or PDL2-Fc promotes de novo human Treg induction and limits Treg
plasticity. Interestingly, we also found that agonizing PD1 within myeloid cells inhibits inflammatory cytokines
that are known to promote Th1/17 development and destabilize Tregs in MS and EAE. Therefore, we will test
our hypothesis that PD1 agonist monotherapy could effectively restore immune tolerance by directly enhancing
Treg homeostasis while quenching effector T cell responses in EAE and MS. Based on our exciting preliminary
finding that IL-2 directly induces PD1 in CD4+ T cells and that combining low-dose IL-2 with PD1 agonists
synergistically boosts human Treg induction,
we will also investigate if combining low-dose IL-2 with PDL1/2-Fc
will synergistically boost MS patient Treg responses.
Because IL-2 can still promote effector T cell responses,
combining PD1 agonist with low-dose IL-2 may also restrain any undesired direct effect of low-dose IL-2 on
boosting effector T cells. In addition, PD1 agonist might further complement low-dose IL-2 by targeting other
important cell types unaffected by IL-2 (e.g. myeloid cells). In Aim 1, we will test the translational relevance of
PD1 agonism monotherapy by treating MS patient immune cells in vitro, and by treating humanized PD1 knock-
in mice with EAE in vivo. In Aim 2, we will test PDL1/2-Fc and low-dose IL-2 combination therapy by treating
MS patient immune cells in vitro, and by treating humanized PD1/IL-2 receptor alpha (RA) double knock-in mice
with EAE in vivo, including single-cell RNA sequencing of immune responses in treated mice. In summary, we
will explore the efficacy of a never tested PD1 agonist/low-dose IL-2 combination therapy strategy in EAE and
MS to
address unanswered questions around how PD1 agonism promotes human immune tolerance, the
translational potential of PD1 agonist therapeutic strategies, and how to implement them in CNS autoimmunity.

Public health relevance
Narrative Multiple sclerosis (MS) is a debilitating demyelinating disease of the central nervous system (CNS) that affects approximately 2.5 million people worldwide. There remains an unmet clinical need for new therapeutic strategies that can restore and sustain long-term immune tolerance in MS patients. The current proposal is aimed at understanding PD1 signaling in MS patients, a major pathway implicated in peripheral immune tolerance, and leveraging these insights to maximize the efficacy of PD1 agonist monotherapies along with low-dose IL-2 combination therapies in clinically relevant MS models. The successful completion of this clinically-oriented proposal has the potential to impact treatment for MS, as well as other inflammatory and autoimmune diseases.